Skeletal Muscle: Development, Regeneration and Disease

SUMMARY The goal of the “Skeletal muscle: development, regeneration and disease” conference is to bring together international leaders in skeletal muscle research to provide a forum for cutting edge genetic, cellular and molecular biology underlying muscle development, regeneration and disease. This Frontiers in Myogenesis series organized by the Society for Muscle Biology has been held every three years for the last twenty years and has successfully defined the state of the art in the field. The 2021 meeting will not only discuss recent discoveries in skeletal muscle development and repair, but will also encompass advances in our understanding of human diseases, including muscular dystrophies and cancer. Our keynote speaker will be Dr. Eric Olson, who has performed exceptional work in muscle development and developed therapeutic strategies for treating Duchenne muscular dystrophy. Eleven plenary sessions are planned to address the following topics: cellular and molecular dynamics of skeletal muscle development, myoblast fusion and muscle growth, muscle stem cell regulation, epigenetic regulation of skeletal muscle, iPS cells, bioengineering and emerging technologies to study and repair skeletal muscle, muscle metabolism and cancer, muscle tissue and disease models, microenvironment in skeletal muscle repair and disease, muscle disease mechanisms, and translating skeletal muscle science into new therapies. Invited speakers (36) have been selected for their scientific excellence, with particular attention to appropriate representation (42% women/minorities) and geographical diversity (39% are from non-US countries). In addition, 19 short talks will be selected from submitted abstracts to provide opportunities for postdocs and students to present their work. Speakers are explicitly required to talk about unpublished work, to ensure scientific discussions focused at the forefront of the field. In addition, we will have three poster sessions each accompanied by a “posters blitz” where poster presenters will give a 1-minute talk to highlight/advertise their work. To further foster interaction, we will organize lunch sessions so that speakers are evenly distributed and attendees can sign up to join their table. Finally, we have included two professional development sessions to discuss grant application, as well as diversity and inclusion in science. This Conference will provide a forum for discussing recent discoveries in skeletal muscle research, and foster cross-fertilization among investigators from diverse areas and backgrounds, to further advance our understanding of muscle biology and facilitate the development of translational efforts for potential therapies for muscle diseases.

Public health relevance
NARRATIVE The goal of the 2021 Frontiers in Myogenesis Meeting entitled “Skeletal muscle: development, regeneration and disease” is to bring together international leaders in skeletal muscle research to provide a forum for cutting edge genetic, cellular and molecular biology underlying skeletal muscle development, regeneration and disease. We have assembled to speak an outstanding group of both established investigators and ‘rising stars’ from around the world, but have also dedicated a third of the slots to short talks selected from abstracts, to ensure representation of exciting new developments and provide opportunities for young investigators to present their work to the muscle community. This Conference will foster cross-fertilization from diverse areas of research, to further advance our understanding of muscle biology and help in development of translational efforts for potential therapies for muscle diseases.